Developmental control of inflammatory memory in atopic dermatitis-like skin disease

Abstract
Atopic dermatitis (AD) is a chronic skin condition characterized by T cell-driven Type 2 inflammation. The MC903-
induced dermatitis model has enabled dissection of pathways driving acute AD-like disease such as keratinocyte
TSLP production and Th2 signaling; however, its ability to model persistent disease states remains unexplored.
Using a repeated-challenge protocol with MC903, we found that adult mice undergoing a primary bout of AD-like
inflammation develop persistent, tissue-specific inflammatory memories in skin that manifest as exaggerated
pathologic responses during secondary MC903 challenge. This aligns with the emerging idea that AD chronicity
stems from local memories of inflammation that persist in healed lesions and exacerbate future disease flares.
However, AD in childhood follows a distinct course, with a unique immune composition and lower incidence of
chronic disease. We thus tested our model in neonatal mice, and despite observing similar primary response
kinetics to MC903-treated adults, we strikingly saw no signs of aggravated pathology during secondary MC903
challenge. This suggests that AD-like inflammatory memory fails in early life. Characterizing the cellular and
molecular mediators of these divergent skin phenotypes will be the focus of our proposed work.
Our data suggests that inflammatory memory in adults is driven by the emergence of Type 1 (T1) immune
features in skin such as T1 tissue-resident memory T cells (Trms), mirroring recent findings in human AD.
Transcriptional profiling suggests fibroblasts help to organize these networks by supporting T cell positioning and
Trm development within inflamed adult skin. Given emerging data to suggest that neonatal T cells and fibroblasts
exhibit distinct inflammatory behaviors from their adult counterparts, we hypothesize that inflammatory memory
is impaired in neonatal skin due to age-related differences in T cell and fibroblast function. To test this, we will
first use lineage tracing to define the fates and phenotypes of adult and neonatal T cells during AD-like
inflammation in developing and adult skin (Aim 1). Subsequently, we will interrogate fibroblast-T cell interactions
in the atopic skin of adult and neonatal mice using in vivo profiling via scRNA-seq and immunofluorescence
staining as well as in vitro functional assays involving fibroblast-T cell co-cultures.
Our work is conceptually innovative and clinically relevant, especially given the growing incidence of chronic AD
in adults. Completion of the proposed work will clarify the basic mechanisms by which neonatal skin escapes
inflammatory memory, potentially aiding in the identification of new therapeutic interventions for chronic AD.

Public health relevance
Project Narrative Atopic dermatitis (AD) is a T cell-driven inflammatory skin condition that often presents differently in adults and children, with adults more likely to experience persistent, recurring symptoms. Using a mouse model that mimics these age-related disease features, we found that adult skin "remembers" AD-like inflammation and reacts more strongly to future triggers, while infant skin does not develop this inflammatory memory. This work will investigate whether T cells and supporting structural cells in the skin known as fibroblasts behave differently in adult and infant skin, leading to differences in inflammatory memory.